IGF::CL::IGF:THIS SERVICE IS FOR THE MEETING PLANNING AND ADMINISTRATION: WOMEN'S TRAUMATIC BRAIN INJURY WORKSHOP DECEMBER 18-19, 2017 POP JULY 24, 2017 TO APRIL 20, 2018.

THIS SERVICE IS FOR THE MEETING PLANNING AND ADMINISTRATION: WOMEN'S TRAUMATIC BRAIN INJURY WORKSHOP DECEMBER 18-19, 2017 POP JULY 24, 2017 TO APRIL 20, 2018.